Oligodendrocyte Progenitors and Mechanisms of Human Vascular White Matter Injury

Project Summary
Progress to define mechanisms of white matter injury (WMI) in vascular cognitive impairment and dementia
(VCID) has been hampered by fundamental gaps in our understanding of the vascular and glial mechanisms
related to the pathogenesis of remyelination failure, a hallmark of VCID. We propose a highly integrated
analysis of the interplay between microvascular and oligodendrocyte progenitor cell (OPC) contributions to
VCID pathogenesis. We will mechanistically link dysfunctional reactivity and inflammation of the WM
vasculature to novel perivascular disturbances in OPC responses to WMI that appear central to myelination
failure in VCID. We will test the over-riding hypothesis that dysfunction of white matter arterioles
establishes selectively vulnerable zones of perivascular WMI from oxidative and nitrosative stress that
result in functionally dysmature white matter niches associated with aberrant OPC migration,
proliferation and differentiation to myelinating oligodendrocytes. This hypothesis is supported by our
recent studies (Bagi et al., Ann Neurol 2018; 83:142-152) that identified selectively impaired vasodilator
function of human WM penetrating arterioles in microvascular brain injury (mVBI) in similar white matter
regions where disrupted maturation of pre-myelinating OPCs occurred. In all three aims, we will employ a
unique collection of human rapid autopsy brains from a large cohort of cases with VCID where white matter
hyperintensities (WMHs) were identified by ante-mortem MRI. Although WMHs are widely used clinically to
identify patients at risk for cognitive decline, their pathological basis is poorly defined. In aim 1, we will define
mechanistic relationships among impaired cholinergic vasodilation of white matter arterioles, high vascular wall
shear stress and WMI arising from augmented production of reactive oxygen and nitrogen species. We will test
the hypothesis that impaired cholinergic vasodilation exposes endothelial cells in WM penetrating arterioles to
a high level of wall shear stress, which induces augmented production of reactive oxygen and nitrogen species
in mVBI. In aim 2, we will define molecular disturbances in the OPC-vascular niche that contribute to
myelination failure in mVBI. We will focus on the role of vascular factors in aberrant OPC migration,
proliferation and maturation. We will capitalize on several new lines of data that demonstrate novel
perivascular injury responses of OPCs at the level of WM arterioles and capillaries. In aim 3, we will define
vascular extracellular matrix mechanisms related to hyaluronic acid (HA)-mediated dysfunction of WM
arterioles. We will integrate approaches using murine and human vessels to define the role of various forms of
HA in vascular inflammation, loss of vascular integrity and abnormal leukocyte adhesion and extravasation
across the vascular endothelium. Our over-riding objective is to provide a mechanistic molecular explanation
for the distinct OPC-vascular processes that render aging human white matter particularly susceptible to
microvascular WMI in order to develop therapies that promote remyelination in chronic WMI.

Public health relevance
Project Narrative This proposal focuses on recently discovered mechanisms of impaired regeneration and repair of diffuse human white matter lesions that we propose are central to vascular brain injury and cognitive decline associated with aging and vascular dementia. We will employ pioneering vascular physiology and molecular approaches to define how chronic injury and inflammation of human white matter blood vessels contributes to the progression of white matter injury by studying vessels from MRI-defined lesions from human autopsy brains from patients confirmed to have cognitive decline. The role of disrupted white matter blood flow will be related to disrupted maturation of a key brain cell type (the oligodendrocyte progenitor) that appears to play a central role in aberrant brain recovery (remyelination failure) after white matter injury to be defined by MRI.